Peripheral Artery Disease: Long-term Survival & Outcomes Study (PEARLS)

Project Summary/Abstract Background: Peripheral artery disease (PAD) is a common and highly morbid condition. Nearly 25% of patients die within 3 years of diagnosis, likely due to a high incidence of cardiovascular (CV) events: myocardial infarction (MI) or stroke. A significantly larger proportion experience disability due to leg pain, poor mobility and amputation. The cost of PAD-related hospital care alone exceeds $21 billion. However, research regarding long-term survival, CV, and limb outcomes in PAD and the impact of existing treatments remain limited in large part due to the poor accuracy of PAD diagnosis codes. Our team has developed a novel approach using natural language processing (NLP) to identify PAD patients with a high degree of accuracy within the Veterans Health Administration (VHA). Significance: The Peripheral Artery Disease: Long-term Survival & Outcomes Study (PEARLS) study will advance scientific knowledge for PAD in several ways. We will use our NLP tool to assemble one of the largest cohorts of PAD in the world and follow them long-term to assess the trajectory of survival and clinical outcomes, evaluate utilization of recommended treatments (medications, risk factor control and revascularization) and the association of above treatments with the above outcomes. Collectively, our work will address important gaps in PAD research and yield insights regarding strategies to improve care delivery in this high-risk population. Innovation: The use of an informatics-based method to assemble a cohort of newly diagnosed PAD patients in a large integrated health system is highly innovative. We believe that our approach for cohort identification will be transformational and promote big data analytics for research, improving care delivery, and future clinical trials. Specific Aims: A1. Develop a national cohort of Veterans with newly diagnosed PAD using a novel NLP algorithm. A2. Examine patterns of medical and invasive management and determine patient- and facility-level correlates. A3. Determine the impact of medical and invasive management of PAD on long-term outcomes. Methodology: We will implement our NLP algorithm to identify patients with new PAD diagnosis in VHA during 2015-2020 and obtain data on clinical and treatment related variables. We will follow our cohort longitudinally for mortality, CV events (MI, stroke) and limb events (amputation). We will examine utilization of PAD treatments and risk factor control, identify patient-level and hospital-level predictors of treatment using multi-level models. We will use discrete survival models to evaluate the association of PAD treatments with long-term outcomes. Implementation/Next Steps: Key deliverables will include a) an understanding of which patient groups are at greatest risk for mortality and adverse outcomes; (b) determining the relative impact of PAD treatments on long- term outcomes which can be useful for decision-making and c) an assessment of site-level variation in treatment patterns. We envision that our findings will help us develop comprehensive disease management program to improve quality of care and reduce disparities in use of effective treatments.

Public health relevance
Project Narrative Peripheral artery disease (PAD) is a common and highly morbid condition that is a major cause of leg amputation, and associated with a high risk of heart attack, stroke and death. We propose to create a large cohort of PAD patients who will be identified using a novel method developed by our research team and followed long-term to advance our understanding of the trajectory of survival and clinical outcomes in PAD and the impact of existing treatments on patient outcomes. Our work will advance PAD research and provide important insights regarding how best to improve PAD care.